Optimization of Targeted Nuclease Mediated HDR Events in Inbred Mouse Zygotes

PROJECT SUMMARY/ABSTRACT Nuclease-mediated homologous directed repair (HDR) in mammalian embryos remains inefficient and unreliable despite recent advances in its development. DNA repair following cutting by nucleases manifests as either nonhomologous end joining (NHEJ), a rapid imprecise repair mechanism, or less commonly and in the presences of donor DNA, HDR with its perfect integration into the genome. HDR efficiency is affected by multiple variables, including the target cell's differentiated state, donor DNA and targeting-nuclease. Current optimization approaches using reporter constructs for HDR in preimplantation embryos do function but are limited to active genes. Where embryos are developed to term, the testing of multiple HDR variables is resource intense. Alternatively, using immortalized cell lines does not accurately reflect the zygote phenotype. The broad goal of this work is to significantly improve the reliability and efficiency of targeted nuclease- mediated HDR by developing and validating a high-throughput, low-cost approach capable of testing multiple variables for targeting HDR directly in mouse zygotes, and making this information publicly available. In our innovative approach, pools of ~50 zygotes are microinjected with a regent test regime (i.e., testing singly, the multiple variables involved), these pools are grown in vitro and harvested at E3.0, and analyzed for targeting efficiency via DNA sequencing focusing on and spanning the targeted region. This uses a single-molecule real- time high-throughput sequencing (HTS) system yielding ~5,000, 8-10kb amplicon reads/regime tested, and will provide an unprecedented overview of the majority of nuclease-mediated events per microinjection regime tested, including allele frequency, i.e., HDR vs. NHEJ vs. wild type. The approach is not impacted by downstream variables, including attrition to live born, or complicated by individual animals' mosaicism. This will reduce costs per microinjection regime tested to <10% vs. that for live-born or fetus-derived data. Powerfully, the approach allows comparative evaluation of 10-15 microinjection regimes simultaneously, a feat nearly impossible when developing zygotes to fetuses or term, due to low survival, high costs, and time constraints. We will: (Aim 1) Establish and validate, using preimplantation mouse embryos, a HTS-based analytical strategy that precisely determines the targeted allele frequency and accuracy of targeted nuclease-mediated DNA repair events, including HDR, for three selected genomic regions; (Aim 2) Test the principal variables involved in targeted nuclease-mediated HDR, with a focus on DNA format, using the platform developed in Aim 1. For both aims and all three targeted regions, the optimal microinjection regime will be validated by repeating the regime and bringing zygotes to term, followed by determination of germline transmission frequency. This overall approach will provide a deeper understanding of the control of HDR vs. NHEJ in mouse zygotes, allowing extensive, controlled manipulation of the mouse genome and potentially that of other species, leading to a greater understanding of human disease via efficient manipulation of the mammalian genome.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Modern genetic editing systems allow the precise targeting and modification any part of the genome, opening infinitive possibilities in the genetic modification of species, including that of laboratory mice, whose genome can be altered to model human diseases and are key to biomedical research. However, such targeted editing remains unreliable and inefficient, as it is affected by multiple experimental variables. The project will develop and validate a resource efficient method that simultaneously tests the effects of multiple variables on the efficiency and precision of genome editing in mice, examining the genetic changes at an unprecedented level of resolution, enabling investigators to more precisely modify the mouse genome and thereby further advance the understanding of human disease.